GPCR anterograde trafficking

Summary
G protein-coupled receptors (GPCRs) regulate a wide range of physiological and pathological processes
and are important targets of therapeutics. As the cell surface is the functional destination for most GPCRs,
defective cell surface delivery leads to GPCR dysfunction and is clearly associated with the pathogenesis of
human diseases. However, the molecular mechanisms underlying the anterograde transport of nascent
GPCRs from the endoplasmic reticulum (ER) to the cell surface en route pass through the Golgi apparatus
remain poorly elucidated. In this proposal, we will define the roles of several newly identified regulators,
including cargo receptors, ufmylation, protein complexes, post-Golgi carriers and exocyst, in the recruitment
to COPII vesicles, ER-Golgi-cell surface delivery, and formation and plasma membrane tethering of Golgi-
derived carriers of GPCRs. The proposed research is a continuation of our long-standing efforts to study the
anterograde trafficking of GPCRs, which have led to the discovery of a number of structural determinants
and regulatory proteins essential for GPCR export and segregation. As in the past, we will employ state-of-
the-art biochemical, immunochemical and live cell imaging techniques to dissect the mechanistic aspects of
GPCR trafficking along the biosynthetic pathway. These studies will reveal novel mechanisms that govern
the forward trafficking and sorting of GPCRs and have a broad impact on the research of GPCR superfamily
and general membrane trafficking. The information generated from these studies may create new avenues
for drug design and treatment of diseases involving aberrant trafficking and function of GPCRs.

Public health relevance
Project Narrative This proposal will define the novel molecular mechanisms that govern the targeting of G protein-coupled receptors to the functional destination. These receptors regulate a variety of cell functions under the physiological and pathological conditions and are the most heavily investigated drug targets. The successful completion of these studies may create new avenues for drug design and treatment of diseases involving aberrant trafficking and function of G protein-coupled receptors.